Light Weight Modeling of Epstein Barr Virus

DESCRIPTION (provided by applicant): Eipstein-Barr virus (EBV) infects more than 90% of all humans, usually without symptoms. It can also be responsible for acute infectious mononucleosis (AIM) and is associated with fatal malignancies including immunoblastic lymphoma, Hodgkin's lymphoma, Burkitt's lymphoma, nasopharyngeal carcinoma and X-linked proliferative disorder (XLP). Our long-term goal is to understand these processes in sufficient detail to guide clinical intervention. Our overall model of normal and malignant EBV biology puts us in a good position to build computer models of EBV infection. Our specific aims include the following: Evaluate the relative impacts of various factors known to play a role in EBV biology. Assess the probability of the varying fates of a cell once it has entered a particular infected state. Understand the overall dynamics of these models as dynamical systems. This includes distinguishing possible long-term behaviors and the transitory states that lead to them. We will pursue these goals by building and analyzing multiple light weight computer models of EBV infection. By light weight we mean that these models are easy to write, modify and run. This will allow investigations not possible with larger agent-based computer models. Epstein-Barr Virus is widespread in the human population. While it is usually asymptomatic, it is also associated with fatal malignancies. Computer simulation is a way to study the normal asymptomatic course of this infection and the ways in which this turns malignant. We hope that a better understanding of these processes will show us how they can be controlled.